Missense Variants in Myosin Binding Protein C that Cause Hypertrophic Cardiomyopathy

Patients with hypertrophic cardiomyopathy (HCM) experience a high symptomatic burden, heart failure and
lethal arrhythmias. While HCM has been recognized as a disease of the sarcomere for >30 years, the disease
mechanisms for sarcomeric gene variants are not well defined, limiting the precision and efficacy of treatment
options. Heterozygous variants in the gene myosin-binding protein C (MYBPC3) cause half of all cases of
familial HCM. About 15% of these are missense variants that cluster in interior protein domains C3 and C6
which have uncertain binding partners or function. Computational predictions combined with our
published and preliminary experimental data support the hypothesis that missense variants in C3 and
C6 domains lead to perturbation of multiple protein-protein interactions that are critical for the normal
function of MyBP-C (the protein encoded by MYBPC3). In Aim 1 we will apply TurboID proximity labeling to
wild-type (WT) and mutant MyBP-C. In preliminary data we have identified >200 novel and unique neighboring
proteins to WT MyBP-C. Comparing C3 and C6 mutants to wild-type MyBP-C, relative abundances of
sarcomeric, cytoskeletal and ribonucleoprotein complexes are reduced, while abundances of ribosomal and
chaperone proteins are increased. We will explore consequences of these altered interactions by assessing
changes in myosin conformation, local translation, and chaperone-mediate protein turnover. We expect to find
that interactions with multiple proteins of diverse function are either strengthened or weakened by the presence
of missense mutations in MyBP-C. Overcoming this perturbation in protein interactions with gene replacement
by wild-type MyBP-C is the focus of Aim 2 where we will test the hypothesis that the mutant protein can be
stoichiometrically replaced within the sarcomere by wild-type MyBP-C. We will transduce patient-derived
inducible-pluripotent cardiomyocytes expressing C3 or C6 missense variants with adeno-associated viral
vectors expressing wild-type MyBP-C or a lentiviral vector expressing a “titratable” wild-type MyBP-C-FKBP12
fusion protein that enables dose-response studies. The outcome measures will be the molar ratio of mutant to
wild-type protein, and contractile and relaxation velocities. In vivo studies of gene replacement in a new
Arg506Trp MYBPC3 knock-in mouse model will complement the hiPSC-CM experiments. This application
explores several novel aspects of MyBP-C biology and features unique reagents and advanced proteomic
techniques. Successful completion of these aims will uncover new biology in MyBP-C by defining an expanded
protein neighborhood, by revealing disease mechanisms for missense MYBPC3 variants, and by testing a
gene displacement strategy that leverages endogenous regulation of sarcomeric stoichiometry and could be
broadly applicable to missense variants in any sarcomere gene. Our investigative team, composed of a mix of
senior, highly experienced investigators and talented junior investigators with unique skill sets, is well poised to
achieve these goals.

Public health relevance
Hypertrophic cardiomyopathy (HCM) is a common genetic heart condition that causes sudden cardiac death and congestive heart failure, and for which current treatments do not slow or prevent progression of the condition. The gene that is most commonly mutated in HCM is called myosin binding protein C. The goals of this study are to understand how mutations in myosin binding protein C affect how the protein associates with other binding partners, and whether these effects can be reversed therapeutically by delivery of the normal protein using gene therapy.